Novel strategies for high-specific multiplexed imaging of genomic interactions by signal amplification

Summary
Cells carrying the same DNA sequence can exhibit heterogeneous gene expression, leading to phenotypic and
functional diversity in both healthy and diseased states. This heterogeneity fundamentally arises at the nucleus
level often from different spatio-temporal patterns of genomic organization, which could differentially influence
the frequency and strength of the physical interactions among genetic elements related to gene expression.
Disruptions in these interaction patterns are often associated with disease, and accordingly, there is a growing
interest in advancing tools for identifying abnormal spatial patterns and contact profiles of the genome. DNA
fluorescence in situ hybridization (FISH) is intrinsically a single-cell assay and suitable for probing cell-to-cell
variation as well as targeted detection of chromosomal interactions. However, the use of DNA FISH for high-
throughput and high-resolution proximity detection is presently limited due to the lack of strategies enabling
multiplexing and high-specific labeling with low background signal. This project will devise two separate FISH
approaches that address the multiplexing and labeling challenges of DNA FISH by making novel use of our lab's
recently developed Signal Amplification By Exchange Reaction (SABER) method (Nature Methods, 2019), which
can simultaneously increase imaging throughput and multiplexing levels. Specifically, the first aim will introduce
a variant of the SABER method that only allows signal amplification upon physical contact between a pair of
FISH probes. This method will be optimized for DNA FISH and its wide versatility will be demonstrated in the
second aim, in the two separate applications: 1) for high-specific and low-background labeling of short DNA
targets and 2) a correction-free (i.e. no channel alignment) one-step colocalization assay for detection of distal
DNA sequences in close 3D proximity. The outstanding research environment of the Wyss Institute for
Biologically Inspired Engineering at Harvard University will offer numerous resources critical for the successful
completion of the proposed goals and ensure the maximum impact of the research given the institute's core
focus is on novel technology development and translation. The sponsor of the project, Dr. Peng Yin, and his
team who have expertise in developing DNA-based molecular devises, imaging, and experience with
chromosomal studies will provide detailed technical support and personalized mentorship. The successful
completion of the aims will thus bring new methodologies to the growing scientific community at the interface
between chromosome conformation capture (3C) and FISH for cross-validation of contact profiles and will further
expand the utility of FISH in potential diagnostic applications.

Public health relevance
Project Narrative Profiling the spatial proximity of genes and their regulatory elements is one of the critical steps towards developing a fundamental understanding of regulatory processes as well as defining nuclear disorders. Microscopy-based methods have the potential to be applied in research and clinical settings to directly identify healthy and abnormal DNA-DNA contact patterns at the single-cell level, but their robustness and utility are presently limited due to the lack of strategies that simultaneously enable multiplexing (i.e. identifying multiple genomic targets within the same sample), high-throughput (i.e. fast image acquisition), and high-specific target labeling (i.e. low false positives). This project focuses on developing novel DNA-based imaging probes and new experimental approaches to address existing challenges of imaging-based detection of DNA-DNA contacts at the single-cell level.